Evaluating the Effectiveness of an Online Small-Group Self-Management Workshop for Rural Caregivers of Individuals with Alzheimer Disease and Related Dementias

Project Summary Abstract N/A

Public health relevance
Project Narrative N/A